IGF::OT::IGF Admin Costs - Contract Orientation & Kick Off Mtg, DTP-17-039, 08/01/17 - 09/30/17, HHSN261201700014I, Analysis of Anti-Cancer Chemical & Pharmaceutical Formulations PRB

Teleconference meeting